Signal-Induced Regulation of Alternative RNA Processing

Project Summary
The ultimate goal of this project is to understand the interplay of cell signaling and RNA processing in shaping
cellular gene expression and function. The specific focus of the current funding period is in unraveling the
regulatory connections that exist between signaling pathways and RNA processing events, and the RNA
binding proteins (RBPs) that maintain these connections. Decades of work have revealed that cell signaling
pathways are central to controlling cellular function in response to environmental cues. Similarly, all of the
steps of RNA processing, including alternative splicing, alternative polyadenylation and regulated mRNA
stability, can be regulated to dictate the identity or abundance of the final mRNA and proteins. Historically,
most work on the impact of cell signaling on gene expression has focused on the regulation of transcription.
Therefore, how cell signaling impinges on the various mechanisms of RNA processing, and conversely, how
RNA processing shapes the cellular response to environmental challenges, remain largely unexplored areas of
research that are critical to our broad understanding of cellular activity. T cell activation provides an excellent a
model system for complex cellular responses, as multiple signaling pathways are triggered downstream of
antigen engagement and act, individually and cooperatively, to induce T cell effector functions. It has been well
documented that T cell activation leads to changes in alternative splicing, polyadenylation and mRNA stability.
Moreover, changes in these RNA processing events impact additional signaling pathway such as apoptosis
and inflammation, which are critical secondary responses to T cell activation. However, many questions
regarding the regulatory connections between RNA processing and signaling remain, including identifying the
RBPs that link signaling to RNA processing, understanding the functional impact of processing events
triggered by one signal on other pathways, and determining how individual RBPs coordinate multiple steps of
RNA processing. This proposal will address these unanswered questions of signal-induced RNA processing by
leveraging recent results and systems to determine how alternative splicing controls apoptosis and interferon
responsive signaling in activated T cells, the proteins that control alternative polyadenylation and mRNA
stability in response to T cell signaling, and a potential new mechanism for the regulation of translation by the
RBP CELF2. Together these studies will provide novel insight regarding the interplay of signaling and RNA
processing in shaping cellular function during T cell activation. Since the signaling pathways studied here are
related to cell growth and death, the insight gained in these studies will be broadly applicable far beyond T cell
biology. In addition, these studies will reveal new paradigms regarding the molecular mechanisms by which
RBPs coordinately control multiple steps in RNA processing. Thus, results from these experiments will
significantly increase the general understanding of the mechanisms that control proteome expression and
cellular function in response to environmental cues.

Public health relevance
Relevance To function appropriately and prevent disease states, all cells in the human body must be able to regulate what proteins they express in response to environmental cues or need. RNA processing, including alternative splicing, polyadenylation and mRNA stability, represent pervasive mechanisms for regulating protein expression and cellular function in response to extracellular triggers. The studies in this proposal seek to elucidate the regulatory pathways and molecular mechanisms by which changes in environment regulate RNA processing, and to determine the consequences of such regulation for maintaining proper cellular function and human health.